Exploring the Role of Novel Aging-Focused Syndemic Conditions on HIV Risk and Quality of Life among HIV-Negative Older Sexual Minority Men

Project Summary
Overview. This study addresses gaps in HIV and behavioral health research among older sexual minority men
(OSMM). Specifically, this project assesses the relative severity and impact of contextually relevant age-related
syndemic factors (age-related discrimination, internalized ageism, aging anxiety, sexual minority specific aging
concerns, social isolation, economic marginalization, and perceived cognitive impairment) and traditional
syndemic conditions (mental health via depression, PTSD, childhood sexual abuse; intimate partner violence;
substance use) among OSMM.9,10 Background. With high prevalence and rising incidence rates, OSMM are
uniquely burdened by HIV.1 This is particularly true for Florida (proposed study site), a state with one of the
highest HIV incidence rates nationally.11 The framework for the study is based on three relevant theories. First,
syndemic theory2 contends that HIV and quality of life (QOL) disparities are propagated by the synergistic co-
occurrence of disease (e.g., health issues, substance use behaviors, sociocultural factors), some of which are
unique to OSMM. Second, the minority stress model3,4 extends syndemic theory by positing that OSMM face
enduring unique stressors resulting from their marginalized identities that perpetuate psychological adversity.
Lastly, intersectionality theory5 posits that OSMM experience worse health outcomes compared to their
younger SMM peers due to the compounding systems of oppression they face due to their multiple minoritized
identities. Objectives & methods. This study’s three aims center on investigating the relative severity and
impact of age-related psychosocial factors and traditional syndemic conditions in explaining HIV and health
disparities among HIV-negative OSMM. Aim 1 examines the severity, frequency, and co-occurrence of
theoretically linked psychosocial problems occurring in HIV-negative OSMM. Aim 2 assesses the influence of
age-related psychosocial and traditional syndemic conditions on engagement in HIV prevention outcomes
(condomless anal sex without PrEP, PrEP adherence) and QOL among this population of OSMM as well as a
potential moderator of these relationships. Aim 3 utilizes tree-based-machine learning to explore interaction
effects between the most influential age-related psychosocial factors and an additive index of traditional
syndemic conditions on HIV risk and QOL outcomes. HIV-negative OSMM (N = 250) between the ages of 55
and 70 years will complete one psychosocial quantitative assessment. Data will be analyzed using tree-based-
machine learning approaches and traditional regression models. Innovation and Impact. This dissertation
study will identify age-related syndemic conditions unique to OSMM to better understand QOL, HIV, and
behavioral health, among OSMM, an under-researched and multiple marginalized group. Findings gleaned will
aid in the future development of HIV and behavioral health related tailored to OSMM and, as a dissertation, lay
the groundwork for the PI’s programmatic research focused on HIV and behavioral health disparities among
older sexual minorities. This proposal is relevant to the NIDA priorities (NOT-MD-19-001).

Public health relevance
Project Narrative Older sexual minority men (e.g., gay and bisexual men; OSMM) are the only age bracket of SMM experiencing an increase (rather than plateau or decrease) of new HIV diagnoses in the U.S.; yet research addressing factors perpetuating this disparity is lacking.1 This dissertation study integrates three complementary theories - syndemic2, minority stress3,4, and intersectionality5 – and utilizes innovative statistical techniques to explore whether a unique set of age-related psychosocial factors (e.g., age-related discrimination, internalized ageism, aging anxiety, sexual minority specific aging concerns, social isolation, economic marginalization, and perceived cognitive impairment) interact synergistically to exacerbate HIV risk and reduce quality of life, above and beyond traditional syndemic conditions (e.g., substance use) among OSMM living in Florida, a state with one of the highest HIV incidence rates in the nation.6 Findings from this study will not only further NIH and U.S. Ending the HIV Epidemic priorities for HIV/AIDS research7,8, but also catapult an emerging investigator’s programmatic research in behavioral health and health disparities among OSMM, a marginalized, intersectionally invisible population.9,10